Molecular Regulators of Mitochondria in Diabetic Cardiomyopathy

Diabetes is at epidemic proportions, with 300 million people worldwide projected to have diabetes by 2025.
Heart disease is the cause of death in 80% of diabetic patients. Heart disease related to diabetes is triggered
by alteration in fatty acid metabolism, hyperinsulinemia, and hyperglycemia and involves complex changes in
signaling and metabolism that may be regulated at multiple levels: 1) altered membrane ultrastructure and
signaling;; 2) altered mitochondrial function and dynamics. As such, the mitochondria and membrane could
be defined as integrative control points in the heart to adapt to diabetic stress and offer novel therapeutic
targets. A metabolic, molecular regulator that integrates membrane and mitochondrial signaling has not been
identified.

Over the last 7 years of funding, this VA Merit proposal has studied caveolin biology in the setting of diabetes,
and then kinase regulation in the setting of ischemia-­reperfusion injury. Building upon our findings, this renewal
will merge these two ideas to propose a novel metabolic, molecular regulator of cardiac function critical to
diabetic cardiomyopathy. Signaling molecules exist as dynamic, spatially organized multi-­protein complexes in
lipid-­rich microdomains of the plasma membrane continuously forming and dissociating under basal or
stimulated conditions. Caveolae are cholesterol and sphingolipid-­enriched structures that form microscopically
distinct flask-­like invaginations of the plasma membrane. Our laboratory and others have shown that the
caveolar structural proteins, caveolins, act as scaffolding molecules to aid in localization and regulation of
receptors and signaling molecules to facilitate coordinated, precise, and rapid regulation of cell function.
Recent evidence suggests that caveolins may exist outside of caveolae and may regulate signaling and
membrane dynamics in distinct organelles. Little information exists regarding protein kinase A (PKA)
localization and functionality in caveolae. Preliminary data suggest that caveolae regulate cellular cAMP. PKA
signaling components are also localized to subcellular compartment where Cav-­3 localizes to and are enriched
in subsarcolemmal mitochondria though little is known in the setting of diabetes. We hypothesize that,
caveolin and PKA may, therefore, be a novel dyad integrating membrane and mitochondria signaling to
maintain cellular and physiological homeostasis in the diabetic heart. The following specific hypotheses
and aims are proposed:

Aim 1: We hypothesize that mitochondria degrade when exposed to diabetic insults and that mitochondrial
localized Cav-­3/PKA will sense cardiac metabolic load, tightly couple electron transport, limit generation of
varied reactive species, and maintain mitochondrial structure and function. To test this hypothesis, we will
determine the role of Cav-­3/PKA in mitochondrial function and structure and the therapeutic potential of
mitochondrial-­targeted gene transfer in the progression of diabetes-­induced cardiac dysfunction.

Aim 2: We hypothesize that plasma membranes degrade with diabetic insults, are less capable of healing and
maintaining coupled insulin receptor signaling, and that membrane-­localized Cav-­3/PKA will regulate these
processes to maintain normal membrane integrity. To test this hypothesis, we will determine the role of Cav-­
3/PKA in membrane repair and signaling.

Public health relevance
This project will study the role of caveolin and protein kinase A (PKA) in protecting the heart from diabetic stress. We will explore the specific role of the caveolin/PKA dyad in various cellular locations and determine if these sites are critical to the pathology in the diabetic heart. Both proteins are involved in regulating cellular functions at the plasma membrane and in mitochondria. How these two specific compartment in a cell are impacted in the setting of diabetes will be the focus of our studies. We will define molecular insights and develop an approach to define and test specific therapeutic approaches to limit cardiac dysfunction in the setting of diabetes.